Novel treatment for Huntington???s Disease

DESCRIPTION (provided by applicant): Because of their degeneracy and selective involvement in most cellular pathways, ubiquitin conjugating and deconjugating enzymes are being explored as therapeutic targets for treating many major diseases, including neurodegenerative disease. The proteasome-associated deubiquitylase (DUB) USP14 plays a key role in regulating proteasomal degradation of pathogenic proteins such as tau, TDP-43 and α-synuclein. Huntington's disease (HD) is a progressive, fatal neurodegenerative disease initially characterized by chorea and gait disturbances. The causative factor is accumulation of polyglutamine (poly Q) expanded huntingtin (Htt) protein, which is polyubiquitylated, but accumulates in inclusion bodies (IBs), rather than being degraded by the proteasome. Results from in vivo models link enhanced degradation of poly Q expanded Htt with reversal of behavioral deficits. Since USP14 has been shown to inhibit degradation of pathogenic, neurotoxic proteins, it is hypothesized that inhibitors of USP14 will accelerate Htt degradation, alleviating HD symptoms. Initial drug discovery around USP14 has not led to efficacious inhibitors, likely owing to both the inherent difficulty in assaying USP14 activity and a lack of cellular models for neurodegenerative disease for testing of hit compounds. These issues are addressed in the current application in two specific aims. In the first aim, two novel assay technologies will be employed to identify developable inhibitors of USP14. Primary screening (of Progenra's collection of 200,000 small molecules) will be conducted using thermal shift, a label free, high throughput-compliant biophysical assay format. Hits from this screen will be confirmed in a proprietary orthogonal assay of USP14 catalytic activity. After additional biochemical testing the compounds will be evaluated further (second aim) in newly developed breakthrough automated, longitudinal single cell imaging models that enable determination, in individual primary neurons, of the half-lives of proteins such as Htt over periods of hours or days. Powerful statistical modeling software developed to monitor clinical trials, applied to these data, will determine the overall risk of cell death following a defined perturbation (e.g., addition of USP14 inhibitor to cells expressing poly Q expanded Htt). These highly predictive models will be employed to determine the impact of novel USP14 inhibitors on both the half-life of poly Q-expanded Htt and proteasomal flux in primary neurons. The goal is to find a potent, selective small molecule inhibitor of USP14 which accelerates pathogenic Htt clearance in neuronal models of Huntington's disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: The ubiquitin deconjugating enzyme USP14 is an attractive target for neurodegenerative diseases (for example, Huntington's Disease) characterized by the accumulation of protein aggregates that are linked to impaired function, because USP14 has been shown to inhibit degradation of pathogenic, neurotoxic proteins. In the proposed project, novel screening assays and a breakthrough single-cell imaging model that measures protein half-lives in primary neurons will be employed to discover and characterize USP14 inhibitors for development as novel therapies for the treatment of Huntington's disease.